Peer-to-Peer Mentoring Platform for Diabetes Management, Training and Support

ABSTRACT The Specific Aim of this proposal is to test the feasibility of developing a web-based peer mentor training and mentor-mentee matching system to help patients better manage their diabetes through mentoring. Effective self-management of diabetes is the key to improving diabetes outcomes and reducing costs. Self-management includes medication adherence, self-monitoring, healthy eating, and physical activity. Yet, many patients do not effectively sustain these required behaviors. Trained peer mentors successfully managing their own diabetes are an effective resource to help struggling patients with uncontrolled diabetes. Randomized clinical trials led by our team (Thom et al. 2013 and Long et al. 2012) found that peer-to-peer mentoring can result in a clinically significant reduction of HbA1c levels (one point), thus improving the quality of life for patients. However, two major challenges prevent widespread adoption of this cost-effective, evidence-based intervention: (1) training peer mentors currently requires live training, which is expensive and not scalable and (2) current methods for appropriate matching of peers and peer mentors are inefficient and time-consuming, and thus not scalable. To overcome these weaknesses, we are developing a web-based program for online training of peer mentors and for assisted-matching of mentors to mentees. The training program and matching criteria will be based on methods previously validated through two randomized clinical trials led by our team. This program is expected to allow for clinical translation of our initial research findings. To achieve our Phase I Specific Aim, we will carry out two Tasks: Task 1: Develop and test the feasibility of remote peer mentor training. Test of Feasibility Task 1: At least 70% of mentors quantitatively show preparedness in a written and phone- based, scenario-driven practicum with our research team (90%+ correct), at least 70% of mentors are satisfied with the training (score at 3 or 4 on a 0-4 Likert scale with 4 being completely satisfied), and there exists a significant improvement in both written and oral exams for mentors from baseline to training completion. Task 2: Develop and evaluate usability of a web-based system to facilitate mentor-mentee matching by medical staff. Test of Feasibility Task 2: At least 70% of administrators and patients are satisfied with the system (Score at 3 or 4 on a 0-4 Likert scale with 4 being completely satisfied). Phase II Plans: Fully develop training modules for peer mentors and make additional improvements, as informed by Phase I; conduct a multi-arm randomized clinical trial to evaluate the efficacy of mentoring on quality of life and diabetes management when those mentors have been trained and matched to mentees using our scalable cloud based training and matching system.

Public health relevance
PROJECT NARRATIVE Peer-to-peer mentoring offers tremendous potential to improve health outcomes and quality of life. Diabetes peer mentors (trained lay individuals successfully managing their own diabetes) are a cost-effective means of improving diabetes management and quality of life for patients with uncontrolled diabetes, especially in resource-constrained health care environments. InquisitHealth's proposed technology system will operationalize at-scale peer-to-peer mentoring by allowing i) remote training of peer mentors and ii) efficient matching of patients with appropriate peer mentors. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The Specific Aim of this proposal is to test the feasibility of developing a web-based peer mentor training and mentor-mentee matching system to help patients better manage their diabetes through mentoring. Effective self-management of diabetes is the key to improving diabetes outcomes and reducing costs.5 Self- management includes medication adherence, self-monitoring, healthy eating, and physical activity. Yet, many patients do not effectively sustain these required behaviors. Trained peer mentors successfully managing their own diabetes are an effective resource to help struggling patients. Randomized clinical trials led by our team have found that peer-to-peer mentoring can significantly reduce HbA1c levels and improve the quality of life for patients with poorly controlled diabetes.1,2 However, two major challenges prevent widespread adoption of this cost-effective, evidence-based intervention: (1) training peer mentors currently requires live training, which is expensive and not scalable and (2) current methods for appropriate matching of peers and peer mentors are inefficient and time-consuming, and thus not scalable. To overcome these weaknesses, we are developing a web-based program for online training of peer mentors and for assisted-matching of mentors to mentees. This system is expected to greatly increase the number of trained mentors and greatly shorten the time it takes for 1-to-1 matching of mentors to mentees. The training program and matching criteria will be based on methods previously validated through two randomized clinical trials led by our team, Thom et al. and Long et al.1,2 Specifically, our web system will closely adapt 36 hours of content previously delivered live to train peer mentors, the written and oral exams used to assess those peer mentors, and the mentor-mentee matching criteria, all of which led to significant improvements in glucose control for uncontrolled diabetes patients. Because we already know that our methods are validated, in this Phase I study, we will focus on testing the feasibility of using a web-based system to achieve the same level of training and matching as in our published studies. If we can achieve this goal, then we will have evidence of a scalable method of translating our findings into clinical practice following final product development. To achieve our Phase I Specific Aim, we will carry out two Tasks: Task 1: Develop and test the feasibility of remote peer mentor training. At the end of Phase II, we will have a total of 19 web-based training modules based on the previously validated content. In Phase I, we will iteratively develop abbreviated versions of 4 modules and complete versions of 3 modules. Forty peer mentor candidates will take a pretest, complete the limited, web-based training prototype, and take a posttest. Test of Feasibility Task 1: At least 70% of mentors quantitatively show preparedness in a written and phone- based, scenario-driven practicum with our research team (90%+ correct), at least 70% of mentors are satisfied with the training (score at 3 or 4 on a 0-4 Likert scale with 4 being completely satisfied), and there exists a significant improvement in both written and oral exams for mentors from baseline to training completion. Task 2: Develop and evaluate usability of a web-based system to facilitate mentor-mentee matching by medical staff. We will develop a cloud-based program to allow staff-assisted matches between mentors and mentees. This program will allow mentors to enter their demographics, clinical, and availability data. Medical staff will interact securely with this database through our web portal and make appropriate mentor-mentee matches using criteria validated in our two prior clinical trials. Eight medical administrators will match a total of 24 patients with peer mentors using the web-based matching system. Test of Feasibility Task 2: At least 70% of administrators and patients are satisfied with the system (Score at 3 or 4 on a 0-4 Likert scale with 4 being completely satisfied). Phase II Plans: Fully develop training modules for peer mentors and make additional improvements, as informed by Phase I; conduct a multi-arm randomized clinical trial to evaluate the efficacy of mentoring on quality of life and diabetes management when those mentors have been trained and matched to mentees using our scalable cloud based training and matching system. InquisitHealth is a software development company that has created HIPAA compliant web-based, peer-to-peer mentoring projects for hospitals, payers, and national patient foundations. Dr. Judith Long at the University of Pennsylvania, Dr. David Thom at the University of California San Francisco, and the entire research team bring deep expertise in diabetes peer mentoring, strong academic and research rigor, and practical experience through work on multiple randomized clinical trials focused in this area. Together, we will translate academic insights, backed by a strong empirical evidence-base, into a scalable, easy-to-implement intervention that can be utilized by health care payers to better manage their diabetes patients. We expect SBIR, VC, and internal funds will be used to this end.